2023 Fibronectin, Integrins and Related Molecules Gordon Research Conference and Gordon Research Seminar

Abstract
We request partial support for the “Fibronectin, Integrin, and Related Molecules” Gordon Research Conference
(GRC) and Gordon Research Seminar (GRS), February 4-10, 2023 at the Marriot Hotel, Ventura, California. This
GRC was scheduled for February 2021, but due to COVID-19-imposed travel restrictions for both US and non-
US participants, a decision was made to postpone it to 2023. The primary goal of this `in person only' GRC is
to increase understanding of how biochemical and biophysical cues from the extracellular matrix (ECM) control
cell-ECM signaling, thus regulating cellular and tissue homeostasis. We will also focus on how perturbations in
this dialogue promote diseases in which the ECM is now known to play a key role, such as fibrosis and cancer.
The latest research that delineates the way cell-ECM adhesion is controlled will be explored in-depth. We will
address how receptor-ECM interaction is sensed and interpreted by cells; how cell-ECM adhesion can be
visualized particularly in living cells; and how cell-ECM communication becomes perturbed in diseases and how
this may be targeted therapeutically. The second goal is to contribute to training the next generation of
scientists, and to foster the careers of junior investigators in this research area. The GRS preceding the GRC
will also maximize the opportunity for trainees to present and discuss their research, and to obtain mentoring
and networking opportunities from established scientists. Both meetings will bring together diverse cell-ECM
researchers and outside experts to share their latest work, thereby stimulating new ideas and solving important
problems in this research area. They will generate new collaborations, thereby sustaining and expanding the
field, and provide new opportunities to develop novel therapeutic strategies. The GRC/GRS will nucleate around
32 invited speakers that include young/mid-term investigators who are performing the cutting edge of research
in the conference topic. In addition to the established invited speakers, each of the sessions will feature talks
from graduate students, post-docs and early career investigators. They will be selected from submitted abstracts
to create opportunities for discussion of late-breaking discoveries and incorporate exciting research as oral
presentations. Moreover, two or three of the best speakers from the GRS will be selected for a short talk at the
GRC. The GRS will include two invited lectures by leaders in the field and 12 talks selected from up to 50 of the
participants. Both programs will hold poster sessions to maximize scientific discussion, some of which will be
selected for talks. New topics for this conference include mechanosensing and mechanobiology; how integrin
structures can lead to the development of therapeutic tools; state-of-the-art microscopy to study integrin recycling
and signaling; and cell-ECM interactions in fibrotic diseases and cancer migration/invasion. Updates on topics
such as tension-sensing and signaling, mechanisms of cell migration, and models of adhesion signaling in health
and disease are also included. Overall, this international conference will showcase the major advances in the
field of cell-ECM interactions research and will be, as it has always been, the seminal conference in the field.

Public health relevance
Project Narrative The “Fibronectin, Integrins and Related Molecules” GRC will take place February 5-10, 2023 in Ventura Beach, California. The purpose of this GRC is to bring together researchers who focus on the role of extracellular matrix (ECM) and cell-ECM interactions in health and disease to share knowledge, to network and establish new collaborations to guide research and improve human health. Other major goals are to highlight young investigators, to provide mentoring for trainees, and to ensure the participation and success of historically under- represented groups in the field of the ECM and its receptors.